The Genetics and penetrance of the Mullerian Anomalies: Addressing the Challenges of the bench to bedside gap.

PROJECT SUMMARY:
The proposed collaboration will develop a multi-pronged research program by combining the expertise of
multiple collaborators to address the genetic causes of Müllerian anomalies (MAs). MAs are a relatively
common developmental abnormality of the Müllerian ducts in females, leading to atypical variations of the
uterine and vaginal anatomy. MAs are complex gynecological birth defects occurring in 5.5% of the general
female population, 8% of infertile women, 13% of women with miscarriages and 24.5% of those with
miscarriages and infertility. Despite the immense impact on woman’s health, the etiology of MAs remains
largely unknown. Although familial inheritance of MAs has been described, no single gene or mutation has
been found to be responsible for MAs. Understanding the heritability and broader health implications of
MAs is desperately needed. This multidisciplinary collaboration provides a unique opportunity to examine
population phenotypes, genetic factors, and molecular mechanisms involved in MAs to bridge clinical and
basic science research on this birth defect. In focusing on these complementary inquiries, this research will
bring together a multidisciplinary team to address significant gaps in our knowledge of this disease.
Further, our team of experts in pediatric gynecology, genomics, developmental biology, and modern data
science will formulate collaborative experimental approaches to collect invaluable preliminary data to
support a future R01 application. The research will address three key gaps in MA studies: (1) analysis of
the phenotypic spectrum and prevalence of MAs diagnoses (including population frequencies and
phenotypic clusters) via the use of the Cerner Real-World Dataset (2) identification of candidate gene
variants potentially causing disruption of reproductive tract development and MAs via genetic testing of
patients with MAs and their unaffected family members using whole exome sequencing (WES) , and (3)
systematic functional testing of selected candidate genes in the pathogenesis of MAs via in vivo functional
genomic analyses. The successful accomplishment of the Aims by this team will address several
recognized short-term and long-term research goals of critical clinical translational value.

Public health relevance
RELEVANCE: Müllerian anomalies (MAs), relatively common yet complex gynecological birth defects, severely impact the reproductive and overall health of females. The cause of the condition is unknown, significantly hampering clinicians’ ability to provide optimum care to these patients. We seek to address this glaring bench to bedside gap for females with MAs and their families, by supporting clinical translational knowledge regarding genetic causes, transmission patterns, and comorbidities associated with MAs.